Human Tumor Atlas Network: Data Coordinating Center Extension

Project Summary/Abstract
We propose to continue managing the operations of the data coordinating center (DCC) for the
Human Tumor Atlas Network (HTAN) with responsibilities for managing, curating, and
disseminating the data and resources generated through this network. We have provided, and
will continue to provide, key services to organize and support the Research Centers that
comprise the network, and foster a community based on collaboration, transparency, and
sharing. Our primary scientific objective is to accelerate the discovery of mechanisms governing
tumorigenesis, progression, and evolution, which will lead to improved prevention and treatment
strategies for patients. We aim to achieve this by providing technology services coupled with
best practices to expedite data acquisition and dissemination to HTAN researchers, as well as
the broader scientific community. HTAN data is now available via the HTAN Data Portal, the
Synapse platform, Minerva, CellXGene, cBioPortal, Google BigQuery, the NCI Cancer Research
Data Service (CDS) and the NCI Image Data Commons (IDC). We will continue to release
HTAN data to the wider scientific community and further develop visualization, annotation, and
analysis tools in order to meet the needs of HTAN and the diverse cancer research community –
including data scientists and statisticians to biologists and clinicians – as new types of data are
generated.

Public health relevance
Project Narrative This is a request for a funded extension for the performance period (09/01/2023 – 08/31/2024). The Human Tumor Atlas Network (HTAN) aims to leverage the power of human genome sequencing and other state-of-the-art profiling technologies, to analyze spatial and temporal molecular changes in individual tumors. The Data Coordination Center (DCC) will ensure that all data will use the same data standards, that all data is hosted in one centralized location, that all data will be shared within HTAN and eventually with the wider scientific community, and that, to maximize the research impact of the data generated, powerful analysis and visualization features will enable researchers to make novel discoveries about the initiation and progression of cancer, as well as the development of resistance to cancer therapy.